Protein Aggregation in Hematopoietic Stem Cells

ABSTRACT
Hematopoietic stem cells (HSCs) regenerate blood and immune cells throughout life. Unfortunately, HSC
function declines with age. Age-related defects in HSCs lead to anemia, impaired immunity, bone marrow failure,
and cancer. Thus, understanding mechanisms that contribute to HSC aging is critical for developing strategies
to enhance regeneration and tissue function in older adults. Proteostasis dysfunction contributes to several age-
associated pathologies, but has not been examined as a mechanism of HSC aging. We recently discovered that
HSCs are particularly dependent on proteostasis to preserve their self-renewal. However, misfolded proteins
arise in HSCs and must be eliminated to preserve HSC fitness. Canonically, the proteasome serves as the
primary pathway for degradation of misfolded proteins, but we recently discovered that HSCs preferentially traffic
misfolded proteins to aggresomes. Aggresomes are cytosolic inclusion bodies containing misfolded and
aggregated proteins that are typically substrates for a selective form of autophagy. Although aggresomes were
thought to specifically form in response to stress, we made the surprising discovery that most young HSCs
contain aggresomes at steady state in vivo, and that Bag3 deficiency impairs aggresome formation, HSC fate
determination, and self-renewal. We also found that HSC aging is associated with a severe loss of aggresomes.
This discovery revealed a new and unexplored aspect of HSC physiology and aging, but why HSCs preferentially
form aggresomes and the impact of their loss on aging is unknown. Based on preliminary data, we hypothesize
that HSCs preferentially traffic misfolded proteins to aggresomes to promote fitness and longevity by preventing
accumulation of protein aggregates and amassing proteomic resources that support regenerative activation and
confer resistance to nutrient deprivation. Furthermore, we propose that diminished aggresome formation in aging
HSCs results from defects in cellular polarity and subsequent accumulation of protein aggregates contributes to
declines in HSC function during aging. In Aim 1, we will use Bag3 knockout mice to test if aggresome formation
is required to protect HSCs against accumulation of pathologic protein aggregates under steady state and stress
conditions. We will also examine if HSCs preferentially store misfolded proteins in aggresomes to sequester
resources to fuel activation and buffer against nutrient deprivation. In Aim 2, we will test if reduced aggresome
formation induces Hsf1 activation, and test if enhancing Hsf1 activity rescues Bag3-deficient HSCs. In Aim 3, we
will examine why aggresomes are lost in aging HSCs. Aggresomes are polarized, but cell polarity is lost in aging
HSCs. We will test if disrupting polarity impairs aggresome formation in HSCs, and determine if rescuing polarity
by inhibiting Cdc42 restores aggresomes in old HSCs. Research outcomes will uncover why HSCs form
aggresomes and reveal how protein aggregation contributes to HSC aging. These studies will identify strategies
to manipulate proteostasis to enhance HSC fitness, prevent blood diseases and extend human healthspan.

Public health relevance
PROJECT NARRATIVE Blood-forming stem cells in the bone marrow regenerate blood and immune cells throughout life. Defects in stem cell maintenance that occur during aging lead to anemia, impaired immunity, clotting disorders and leukemia, but the underlying cause of these defects is largely unknown. This proposal will examine if blood-forming stem cell maintenance depends on trafficking misfolded and aggregated protein into aggresomes, and will identify if dysregulation of these processes contribute to impaired stem cell function during aging.